Prion Clearance and Treatment of Recalcitrant Prion Strains Through Deep PrP Suppression

PROJECT SUMMARY/ABSTRACT
Prion disease is a fatal neurodegenerative disease caused by misfolding of the prion protein (PrP). Lowering
PrP by genetic deletion or pharmacologic means both delays onset and slows progression of prion disease. A
PrP-lowering medicine is now in clinical trials in prion disease patients. Yet despite ample support for PrP
lowering as a therapeutic hypothesis, key questions have remained unanswered due to the lack of potent
PrP-lowering reagents for the whole brain. First, what threshold percentage of PrP lowering is required in order
to halt prion replication entirely, and tip the kinetics towards prion clearance? Second, will ultra deep PrP
lowering prove effective against recalcitrant prion strains that show only limited response to 50% PrP lowering?
In this proposal we will use highly potent PrP-lowering reagents to probe the following questions. 1) Quantify
the depth of PrP suppression achievable under a repeated dosing regimen. 2) Determine the trajectory of prion
replication with and without treatment. We will infect mice with prions and harvest brains at timepoints before
and after treatment to determine whether the treatment slows, halts, or reverses replication of prions. 3)
Compare the efficacy of deep PrP suppression to only 50% suppression for a recalcitrant prion strain. Using a
prion strain for which the benefit of 50% PrP lowering is less pronounced, we will ask whether deeper
suppression with chronic treatment confers additional benefit and whether it is capable of keeping animals
alive until end of study at 500 days post-inoculation. Our findings will inform the design of clinical trials in prion
disease by delineating the requirements for efficacy against recalcitrant prion strains and quantifying a
threshold of PrP lowering required to achieve prion clearance.

Public health relevance
PROJECT NARRATIVE Prion disease is a fatal neurodegenerative disease caused by misfolding of the prion protein, or PrP, and new medicines to lower PrP are now in clinical trials. This project aims to identify a quantitative threshold of what percentage of PrP lowering is required in order to halt prion replication and commence prion clearance, and to determine the effectiveness of deep PrP lowering against recalcitrant prion strains that are only somewhat slowed by 50% lowering.